PET imaging for in-vivo quantification of demyelination and cerebral perfusion in Alzheimer's Disease

PET radiotracers targeting amyloid beta (Aβ) plaques and hyperphosphorylated tau, the two major hallmarks of
Alzheimer’s disease (AD), have been instrumental in clinical and research settings to study AD and related
dementia. However, strong evidence indicate the involvement of multiple pathological processes in AD, including
demyelination and vascular dysfunction, that may be coexisting with and could even precede Aβ and tau
neuropathologies. Demyelination has been traditionnally imaged with magnetic resonance imaging (MRI). MR
sequences offer good spatial resolution and sensitivity toward demyelinated areas in the white matter (WM) but
lacks specificity, quantitative value and sensitivity toward gray matter (GM) demyelination. In order to adress
these limitations, [18F]3F4AP was recently developed to provide specific and quantitative measurements of
demyelination with PET. [18F]3F4AP binds to voltage-gated potassium (Kv) channels which are exposed and
increase in expression upon demyelination, thus serving as an indirect biomarker for demyelination. This
compound demonstrated excellent imaging properties with good sensitivity toward demyelinated lesions in
preclinical studies and, more recently, was able to detect lesions in human subjects with multiple sclerosis (MS).
In addition, [18F]3F4AP shows high brain permeability, suggesting that, in addition to measuring demyelination,
this radiotracer could also provide quantitative measurements of cerebral perfusion. In this application, we
propose to characterize [18F]3F4AP’s properties and performance for detecting and quantifying demyelination
and cerebral perfusion in subjects with AD, mild cognitive impairment (MCI), and cognitively normal (CN)
individuals. We will perform the first full pharmacokinetic evaluation of this tracer in human subjects with AD and
subjects with MCI and we will validate simplified imaging protocols and quantification methods towards clinical
translation. We will also assess associations between quantitative measures of demyelination, CBF, Aβ plaques
and tau load.

Public health relevance
PET radiotracers targeting amyloid beta and hyperphosphorylated tau, the two major hallmark neuropathologies in Alzheimer’s disease (AD), have been successfully developed and are now widely used in clinical research. However, strong evidence suggest that additional pathophysiological processes, such as myelin pathology and vascular dysfunction, may coexist and contribute to the etiology of the disease. We propose to characterize the PET radiotracer [18F]3F4AP’s properties and performance in human subjects with AD, mild cognitive impairment (MCI) and cognitively normal (CN) individuals for detecting and quantifying demyelination and cerebral perfusion.